The Multiscale Role of Piezo Channels in Obesity-Associated Cartilage Damage

PROJECT SUMMARY
Osteoarthritis (OA) is a debilitating disease of the synovial joints and is the leading cause of pain and disability
worldwide. OA affects over 30 million Americans, but there are no disease modifying drugs. Obesity is a major
risk factor for OA; however, it has been difficult to disentangle the role of low-level systemic inflammation from
the effects of altered joint loading with increased body mass. While cartilage requires loading to maintain tissue
homeostasis, previous studies have suggested that abnormal loading due to increased body mass may explain
why individuals with obesity experience cartilage damage at elevated rates when compared to healthy weight
individuals. However, many recent studies demonstrate that increased body mass alone does not explain OA
damage in human and animal models, and that adipokines, inflammatory mediators from body fat, play an
important role in OA pathogenesis. Additionally, previous studies from the Guilak lab highlight the synergistic
importance of the mechanosensitive ion channels Piezo1 and Piezo2 in cartilage health and maintenance:
obesity and an OA-relevant inflammatory mediator, interleukin 1 alpha (IL-1α), modulates and sensitizes Piezo
channel function. As such, this proposal investigates if cytokine/adipokine signaling is the mechanism by which
Piezo channels become hypersensitized to mechanical force, ultimately leading to increased chondrocyte death.
The goal of this proposal is to directly investigate the interaction between obesity-associated inflammation and
the mechanosensitivity of chondrocytes. This study on the role of altered mechanosensation in the pathogenesis
of OA with obesity will lead to the ultimate goal of targeting these pathways to develop novel therapeutic
approaches. Specific Aim 1 focuses on determining if obesity-associated inflammatory conditions alter Piezo
expression in cartilage and if this increased expression translates to increased chondrocyte sensitivity to
mechanical loads. This study hones in on key dysregulated adipokines with obesity: IL-1α, Leptin, tumor necrosis
factor alpha (TNF-α), and interleukin 6 (IL-6). Specific Aim 2 uses transgenic mice previously developed in the
lab to investigate if the loss of chondrocyte-specific Piezo1 and/or Piezo2 ion channels protects against cartilage
damage in an in vivo model of obesity and joint injury. Specifically, mice will be fed a high-fat diet (60% fat) and
subjected to a destabilization of the medial meniscus (DMM) surgery, known to evoke post-traumatic OA.
Together, both aims strategically develop atomic force microscopy (AFM) and calcium (Ca2+) imaging techniques
with in vivo assessments of cartilage integrity to complement the use of genetically-modified mice in a model of
HFD superimposed with DMM injury. The results from this study will help identify the mechanisms by which
obesity affects cartilage health, ultimately leading to the development of OA disease modifying drugs, that may
be more broadly applied to other tissues affected by altered mechanosensation of Piezo ion channels.

Public health relevance
PROJECT NARRATIVE Obesity is a major risk factor for osteoarthritis that involves both mechanical (altered joint loading) and biological (systemic inflammation) components, but the interaction between altered mechanosensation and obesity-related inflammation is unclear. The goal of this proposal is to determine if chondrocyte mechanotransduction via the Piezo ion channels is altered by obesity-associated inflammation. These findings will provide key mechanistic insights into the pathogenesis of osteoarthritis that can be more broadly developed into novel therapeutic strategies.